Predoctoral research training at the interface of brain, body, and behavior

Project Summary
The goal of this training program entitled “Predoctoral Training at the Interface of Brain, Body, and
Behavior” (BBB) at Brandeis University is to produce a new generation of scientists equipped to
discover the mechanisms of a broad range of healthy and clinically disordered mental and behavioral
functions by applying both the core concepts and methods of psychology and the interface of these
methods with neuroscience and biomedical research. This new application under NIGMS PAR-17-
341 builds on a T32 program that is expiring after ten years of NIGMS support. Neuroscience at
Brandeis is an umbrella for extensive overlap of Psychology and Biology faculty, but co-training of PhD
students has thus far been prohibited by differences between the Psychology and Neuroscience
graduate programs. The old BBB program supported Psychology PhD students and provided them
with supplementary training in neuroscience and biomedicine, and the new BBB proposes to support
both Psychology and Neuroscience PhD students and to give them complementary co-training in each
other’s disciplines. Psychology appointees will be supported in years 1 and 2 and Neuroscience
students in years 2 and 3, but all will engage in BBB activities from year 1 to graduation. The old BBB
training grant had 3 NIGMS slots, and the new BBB proposes 4 NIGMS slots evenly divided between
the Psychology and Neuroscience, supplemented by one additional slot pledged by Brandeis
University. Psychology and Neuroscience have mutually revised their PhD programs such that BBB
students can satisfy departmental course electives with BBB-specific classes from the other program.
Additional required BBB co-training students includes research mentoring in the same laboratories,
research rotations, a common module for training in rigor and reproducibility, coordinated journal clubs,
and joint colloquia. These BBB requirements, departmental requirements, and enhancement activities
are designed to provide students broad and deep training on specific bio-behavioral problems and
quantitative training in research implementation and rigor as well as mentoring in how to develop,
communicate, and fund an independent scientific program. The training faculty include 12 members
with primary appointments in Psychology and 7 in Biology, all of whom are members of the Volen
National Center for Complex Systems which houses the Neuroscience PhD program. One of the
Psychology BBB faculty is a non-tenure track specialist who teaches and advises students on statistics
and research design, with a special emphasis on methods of rigor and reproducibility. Another major
aim of our program is to grow by attracting and fostering a diverse group of students. Over the past 10
years, 21% of students in the Psychology BBB program have been under-represented minorities, and
the Neuroscience program has enrolled 13-20% URMs per year, and we aim to continue this trend.

Public health relevance
PROJECT NARRATIVE The goal of this training program is to produce a new generation of scientists equipped to discover the mechanisms of a broad range of healthy and clinically disordered mental and behavioral functions by applying both the core concepts and methods of psychology and the interface of these methods with neuroscience and biomedical research. The major innovations are programmatic elements for the co- training of Psychology and Neuroscience PhD students.